Molecular Mechanisms of FUNDC1-Mediated Mitophagy

ABSTRACT
Autophagy is a lysosome-mediated pathway that selectively targets and degrades cytoplasmic content.
Identification of autophagy targets is a critical facet of cellular homeostasis and is mediated by selective
autophagy receptors. Immense progress has been made in characterizing soluble autophagy receptors.
However, mechanisms of recently discovered membrane-embedded receptor Fun14 domain-containing 1
(FUNDC1) remains widely unknown. Located on the outer mitochondrial membrane, FUNDC1 mediates
autophagic turnover of mitochondria, termed mitophagy. FUNDC1-mediated mitophagy is induced in diverse
pathologies and developmental programs. For example, previous studies have demonstrated a physiological
role for FUNDC1-mediated mitophagy in hypoxia-related pathologies, including cancer and ischemia-reperfusion
injury. Preliminary results suggest that FUNDC1-mediated mitophagy is molecularly distinct from other forms of
mitophagy. The overall objective of this proposal is to elucidate the molecular mechanisms of hypoxia-induced
selective autophagy pathways through the characterization of FUNDC1 function. In Aim 1, a domain analysis
approach will be performed to identify functionally important regions of FUNDC1 required for hypoxia-induced
mitophagy. These studies will dissect potential activation events that enable activation of FUNDC1. In Aim 2,
CRISPR-Cas9 technology for high-throughput genetic screens will be used to identify modulators of FUNDC1
turnover. Novel genetic factors that modulate FUNDC1-mediated mitophagy will be characterized for their
function. Taken together, the proposed experiments will provide insight to elucidate mechanisms of hypoxia-
induced selective autophagy and expand putative therapeutic targets for autophagy in hypoxic-related human
pathologies. With the proposed training plan, I will enhance the skills needed to progress my scientific research
career including laboratory technical skills, experimental design, science communication, and mentorship.
Dartmouth College and my mentorship team are well-equipped to ensure success of my research project and
progression to the next step of my academic career as a postdoctoral researcher.

Public health relevance
PROJECT NARRATIVE Autophagy receptors are a critical facet for selective autophagy pathways. This research plan proposes a receptor centric approach to characterize mechanisms of membrane-embedded receptor Fun14 domain- containing protein 1 (FUNDC1) for autophagic turnover of mitochondria in response to hypoxia. The outcomes of this research plan will reveal mechanisms of hypoxia-induced selective autophagy and expand putative therapeutic targets for autophagy in hypoxia-related human pathologies.